Leadership, Planning and Evaluation

Leadership, Planning and Evaluation
Project Summary
The Purdue University Center for Cancer Research (PCCR) was established as a National Cancer Institute
basic science cancer center in 1978. As an NCI basic science cancer center, the PCCR's mission focuses on
basic discovery - discovery that is the foundation through which the PCCR fosters innovative cancer solutions.
To accomplish the discovery mission, Senior Leadership sets the vision, leads planning and evaluation
processes, and oversees progress of the PCCR. The following specific aims will be pursued to enable the PCCR
to achieve its strategic objectives:
Aim 1: Utilize multiple advisory resources, both external and internal advisory committees, to assist
with planning and evaluation.
Aim 2: Utilize effective Senior Leadership to evaluate and monitor planning and evaluation
processes.
Aim 3: Utilize the Executive Committee as the decision-making body to recommend initiatives to the
Director.